Dissecting the thermogenic adipose niche

Project Summary/Abstract
Adipose tissue plays a critical role in the regulation of whole-body energy metabolism, and adipose dysfunction
directly links to the etiology of several commonly seen metabolic diseases, such as type 2 diabetes mellitus
and cardiovascular diseases. There are several different adipose depots dispersed throughout the body. White
adipose tissue (WAT) is the primary site of the triglyceride storehouse. In contrast, thermogenic fat, which
consists of classical brown adipose tissue (BAT) and inducible beige/brite fat, is specialized for thermogenic
energy expenditure. In humans, individuals with detectable BAT have a significantly lower prevalence of
cardiometabolic diseases, pointing to the metabolic benefits and therapeutic promise of BAT. Thermogenic
adipose tissue can rapidly respond to environmental challenges by modulating cellular compositions and cell-
to-cell interactions. Such adaptation is key to maintaining metabolic health. Intercellular communications within
the thermogenic adipose niche orchestrate adipose tissue development and play an essential role in adipose
tissue turnover, expansion, and remodeling in response to external stimuli. To dissect the complex cellular
makeup of thermogenic fat, we performed single-cell RNA-sequencing analysis of BAT from mice housed at
different temperatures. The results revealed a high degree of heterogeneity of thermogenic adipose niche and
showed cold exposure induced dynamic changes of cellular composition in BAT. Importantly, we identified a
novel population of adipose progenitor cells (APCs), which was derived from the vascular smooth muscle
(VSM) lineage and uniquely expressed Trpv1 (transient receptor potential cation channel subfamily V member
1). Lineage tracing studies demonstrated that the Trpv1-expressing VSM-APCs could proliferate and
differentiate into highly thermogenic adipocytes in response to cold stimulation. Work in progress showed that
impaired adipogenic differentiation of Trpv1-expressing APCs resulted in reduced expression of thermogenic
genes in BAT and WAT, suggesting an important role of these cells in thermoregulation. Additional preliminary
data showed that the Trpv1-expressing APCs could respond to local signals and differentiate into thermogenic
adipocytes. These exciting findings have led us to propose a model involving intercellular communications in
which interplays between the APCs and inductive signals shapes adipocyte differentiation and function. In this
proposal, we will test this hypothesis by determining the physiological role of the Trpv1-expressing APCs in
metabolic regulation, identifying the endogenous and exogenous stimuli of Trpv1-positive APCs, and mapping
the cellular interactome of the thermogenic adipose niche using computational tools and spatial transcriptomic
analysis. Successful completion of the proposed studies will provide new insight into the role of intercellular
communications in the regulation of adipose tissue development and function.

Public health relevance
Project Narrative Obesity and its metabolic sequelae place severe medical and economic burdens on the United States, and adipose tissue plays a central role in these pathologies. The proposed research aims to understand the cellular compositions and cell-to-cell interactions of thermogenic adipose tissue. The results will improve our knowledge of the regulation of thermogenic metabolism and may ultimately lead to new therapeutic approaches for the treatment and prevention of obesity and metabolic diabetes.